PREPARATION OF PRESENTATIONS FOR 46TH ASMS CONFERENCE MASS SPECTROMETRY

Evidence for the significant advances made in the Rockefeller Mass Spectrometry Resource in Technological Research and Development can be assessed from the 12 presentations given by members of The Resource at the 44 ASMS Conference in Portland, May 1996. ( One page Summaries of each presentation follow below).